Comparative Medicine and Pathology Training

Project Summary/Abstract
The Comparative Medicine and Pathology training program was initiated in Fall 2003 and over two decades
has consistenUy provided state-of-the-art research training to veterinarians as a pathway to careers as
veterinarian-scientists. Five years of continuing support are requested in the present application, including
support for six postdoctoral trainees in each program year. It is anticipated that most of these individuals will
have completed a residency in veterinary medicine, surgery, or pathology prior to entering the training
program. Selection criteria will include 1) a strong interest in research and a desire for a career in academic
veterinary medicine; 2) academic credentials and performance during clinical training/residency; and 3)
desirable personal characteristics, including integrity, perseverance, and oral and written communication skills.
The training program is located in the College of Veterinary Medicine at the University of Minnesota and is
directed by Drs. Molly McCue, Cathy Carlson, and David Brown. Thirty-four faculty mentors, all members of the
Comparative and Molecular Biosciences (CMB) and/or Veterinary Medicine (VMED) graduate programs, will
participate in the training program. These individuals represent a diverse group of disciplines, including
pharmacology, cell biology, infectious disease, neurobiology, kinesiology, genetics, molecular biology, and
orthopedics. Trainees without a PhD degree will pursue a PhD degree in either the CMB or VMED graduate
program; both are well-organized, multidisciplinary programs created to focus graduate education efforts by
faculty interested in comparative biomedical sciences and the molecular mechanisms responsible for human
and animal health and disease. The goals of our training program are to provide students with broad-based
scientific knowledge, superb communication skills, and advanced research training essential for a career as an
independent investigator.

Public health relevance
Project Narrative There is an ongoing, severe shortage of veterinarian-scientists with the research expertise necessary to pursue careers as independent investigators in biomedical research. These individuals are critical to effectively translating biomedical research discoveries made in animal models into new methods for the diagnosis and treatment of human disease. This "Comparative Medicine and Pathology Training" program at the University of Minnesota will use and improve our established mechanisms of providing a robust research training experience to DVMsNMDs to increase the number of veterinarian-scientists working successfully in biomedical research fields and conducting research around the "One Health" concept for the ultimate benefit of human health.